Development of a rapid, pan fungal diagnostic assay

ABSTRACT
Diagnosing fungal infections faces a number of challenges including a decline in expertise needed for
identifying fungi and a reduced number of instruments and assays specific for fungal identification compared
to bacteria and viruses. These problems are exacerbated by the fact that patients with fungal infections are
often immunosuppressed, which predisposes them to infections from both common and rarely seen fungi.
Historically, molecular diagnostic assays for invasive infections have been labor intensive and required a high
degree of technical expertise. Developing an efficient assay that could use technology as a substitute for
classical mycology expertise has been difficult. While ribosomal ITS sequencing is the gold standard of fungal
molecular diagnostics, it is slow, requires high capital costs, and for many fungi, is not specific enough. This
study will rely on two innovative components that will enable the identification of almost any fungus to the
species level quickly. The first component is a new sequencing technology called nanopore sequencing,
which is fast and inexpensive. The second component will consist of a novel sequencing target called the
intergenic spacer sequence (IGS), which is located within the fungal ribosomal repeat. The IGS is too long to
be covered by traditional Sanger sequencing in a diagnostic assay because multiple reads generated from a
primer walk would be required, so it is not used for fungal identification. However, nanopore sequencing can
easily cover the IGS region in a single sequencing run. To achieve the goal of developing an efficient pan
fungal diagnostic strategy, three aims will test the hypothesis that sequencing a little used, but highly
informative region of the fungal rDNA repeat locus using nanopore sequencing will provide the greatest
specificity and quickest turnaround time to date for fungal identification. These aims are: 1) Generation of a
fungal intergenic spacer sequence reference sequence database within the GenBank RefSeq (reference
sequence) Targeted Loci Project, called the Fungal IGS RefSeq database 2), Development of a rapid assay
for fungal identification based on nanopore sequencing of the intergenic spacer sequence, 3) Comparison of
a nanopore sequence diagnostic assay against current laboratory fungal diagnostic methods. The long-term
goal that this project will enable after its completion will be the future development of a rapid, inexpensive,
assay that is pan fungal in capability.

Public health relevance
PROJECT NARRATIVE Delayed diagnosis of fungal infections is a proven risk factor for increased morbidity and mortality. There currently is no FDA approved, benchtop, pan fungal diagnostic assay that is fast, has inexpensive equipment, can be used directly on pure cultures or clinical specimens, or on mixed cultures. This proposal will use a new, inexpensive sequencing technology called nanopore sequencing, and a little used region in the fungal ribosomal repeat called the intergenic space region to yield a rapid diagnostic assay using a single sequence.